SIGNIFICANCE OF AIRWAY RESPONSIVENESS AND AIRWAY INJURY IN OZONE SENSITIVITY

The study is attempting to correlate the physiological decrements in airway responsiveness with biochemical endpoints in ozone injury. Subjects are exposed to either ozone or filtered air while exercising for 6 hours. Eighteen hours later, bronchoscopy, bronchoalveolar lavage, and endobronchial biopsy are performed. Subjects are monitored in the GCRC.